Harnessing Trained Immunity as a Radiation Medical Countermeasure

PROJECT SUMMARY
Radiation exposure causes acute and chronic injuries to cells, tissues, and organs that induce inflammatory and
immune complications. Among the most serious complications is predisposition to life-threatening opportunistic
infections due to hematopoietic and immune system damage. Long term effects referred to as delayed effects
of acute radiation exposure (DEARE) can also occur leading to progressive organ system failure and increased
risk of developing cancer or other chronic diseases. Our radiation MCM development research program centers
on the concept of targeting innate immune pathways to induce protective anti-microbial immunity and restore
immune system homeostasis. We discovered that treating mice with CpG-DNA, a Toll-like receptor 9 (TLR9)
agonist found in bacteria and mitochondria, can restore anti-microbial immune function in mice exposed to
immune-compromising total body irradiation (TBI) radiation doses. CpG-DNA induces trained immunity in mice
via a mechanism involving mesenchymal stromal cells (MSC) effects on hematopoietic stem cells (HSC). The
immune regenerative activity of CpG-DNA enhances anti-microbial immunity and reduces DEARE. As such, this
project will address the next phases of developing CpG-DNA as a MCM strategy for radiation as well as radiation
with traumatic injury. Given the complexity of radiation and traumatic injuries, we will use systems biology
research methods to explore detailed changes in the hematopoietic and immune system. To implement
translational potential, gender and natural immune “dirty” mice will be included in the experimental design of
these pre-clinical studies. We hypothesize that CpG-DNA treatment will help regenerate hematopoietic system
recovery by acting on bone marrow hematopoietic and progenitor cells to promote early and late recovery
responses in people that may be exposed to radiation with or without trauma. Project aims will (1) systematically
test, develop, and optimize CpG-DNA MCM treatment approaches for radiation injuries, (2) identify functional
effects of CpG-DNA MCM treatments on infection and immune system recovery after radiation with and without
trauma, (3) discover molecular and cellular mechanisms involved in the immune regenerating activity of CpG-
DNA. We hypothesize that targeting innate pathways will signaling “upstream” networks to regenerate
“downstream” injurious complications of radiation exposure by promoting homeostasis and recovery responses.
We expect that the findings from this project will support future translation for CpG-DNA for use in immune
compromised people exposed to radiation or other insults that suppress normal immune function and
homeostasis.

Public health relevance
PROJECT NARRATIVE Exposure to radiation from a nuclear explosion or medical use will cause immune system deficiencies and long- lasting complications due to loss of natural immune balance that is needed for protection from infectious diseases and cancer. This project will advance development of using natural immune system enhancing stimulants called CpG-DNA to regenerate bone marrow recovery after radiation or radiation with combined traumatic injury. Studies are designed to optimize translational methods for using CpG-DNA as a medical countermeasure improve recovery from radiation exposure and trauma.